Large-scale Disease Pathway Discovery by Integrating Tissue-specific Molecular Networks via Hierarchical Bayesian Inference on Graph Neural Networks

PROJECT SUMMARY
Analysis of molecular entities and the interplay between these components provides key insights into genotype/phenotype relationships, functioning of cells/tissues, and etiology of diseases. However, identifying pathways associated with diseases is a long-standing fundamental challenge. One major obstacle is that proteins
associated with a single disease tend to assemble multiple disconnected pathway fragments sparsely embedded in protein-protein interaction (PPI) networks, and each localized connected module contains only a small
fraction of the proteins. Moreover, as diseases manifest themselves in different tissues, the disease modules
and their connectivity patterns tend to be tissue-specific. Although deep learning methods for pathway discovery
show promising results, topological information of disease proteins remain largely unexplored. In addition, deep
learning for network integration fuses tissue-specific networks into a single generic representation that obscures
their distinct yet related features. Recent advancement in graph neural networks (GNNs) gains the capabilities
to exploit topological information in molecular networks. However, since GNNs encode each node’s representing
features by aggregating information from all its neighboring nodes within a neighborhood scope that needs to
be pre-specified, identifying and grouping the loosely linked pathway fragments can be expensive and incomplete. Based on the PI’s pioneering work on developing GNN methods for biomedical interaction prediction, the
overarching research goal for the next five years is to design and develop novel bio-statistical graph learning
strategies for structural characterization of large-scale disease pathways and systematic bio-medical data analytics for a holistic view of molecular and functional relationships. The PI will model GNNs’ exploration for sparse
connectivity patterns of disease proteins as stochastic processes to infer the scope of neighborhood where GNNs
should aggregate information and adaptively sample interactions to identify critical sub-networks. This will enable
us to leverage both node features and topological information to improve predictive performance. To integrate
tissue-specific PPI networks for disease pathway discovery, the PI will augment our GNN inference by creating a hierarchical framework. The framework will consist of a hyper-prior to share complementary information
between the molecular networks at the global level, and tissue-specific priors to capture their distinctive characteristics at the local level. The PI will design both case studies and comprehensive experiments to verify and
interpret predicted disease proteins and modules. Since molecular interactions control cellular processes involving complicated cascades of biochemical reactions and signaling pathways, dysregulation of any component of
these pathways can lead to a broad spectrum of human pathologies including cancer, cardiovascular disease,
neurodegenerative conditions, and metabolic diseases. A holistic view of disease pathways will accelerate the
development of new therapies to combat these diseases.

Public health relevance
PROJECT NARRATIVE Advancing our knowledge of molecular interaction networks is a fundamental goal in Systems Biology. Our proposed research program will create transformative bio-statistical graph representation learning strategies and bio-medical data analytics to elucidate a holistic view of large-scale disease pathways. A quantitative and mechanistic understanding of molecular interactions that construct pathways leading to distinct disease phenotypes will accelerate the development of new therapies to combat many human diseases like cancer, cardiovascular disease, neurodegenerative conditions, and metabolic diseases.